Building Interdisciplinary Research Careers in Women's Health at UC Davis

PROJECT SUMMARY/ABSTRACT
For this administrative supplement to our K12 BIRCWH grant, UC Davis is requesting support to allow
our fourth Scholar, Dr. Adrienne Hoyt-Austin whose background meets the NIH criteria for being from an
underrepresented minority group and disadvantaged background in interdisciplinary women’s health and sex
differences research. This proposed Scholar is within 6 years of a terminal degree and will engage in
interdisciplinary women’s health and/or sex/gender disparities, team science-based research and create an
independent development plan for her pathway to independence. Her research focus is to addressing health
disparities by improving evidence-based breastfeeding support to increase breastfeeding rates, exclusivity, and
duration, especially amongst racial and ethnic minorities. This research addresses two of the BIRCWH
crosscutting themes: 1) health disparities; and 2) interdisciplinary research.
Over the past 21 years, the UC Davis BIRCWH program has trained a sizeable, diverse cadre of
interdisciplinary researchers in women’s health and sex differences and heightened the visibility and prominence
of this research. Led by Dr. Nancy Lane, we continue to build on this strong foundation to increase UC Davis
BIRCWH innovation and impact by fostering an academically stimulating and nurturing environment that
facilitates our objectives. Our short-term BIRCWH objectives are to: 1) provide in-depth, individualized training
and team-based interdisciplinary mentoring to support the independent career development of Scholars in
interdisciplinary women’s health and sex differences research; and 2) advance and achieve high-impact women’s
health and sex/gender differences research by establishing cross-disciplinary collaborations with the UC Davis
schools. Our long-term objectives are to: 1) improve women’s health by enhancing understanding of the unique
aspects of female sex and gender and then translating this knowledge to clinical practice; 2) develop
transformative interdisciplinary team science for women’s health and sex/gender disparities research; and 3)
train leaders in interdisciplinary women’s health and sex differences research.
To accomplish the objectives for this supplement, our proposed BIRCWH Scholar will continue to
participate in: 1) team-based, interdisciplinary mentored research and career development activities; 2) core
courses on grant writing, biostatistics, team science and responsible conduct of research; 3) supplemental
courses tailored to her needs and interests; 4) integrated journal clubs; 5) monthly meetings with the PI and RDs
to discuss research and career progress; 6) an annual symposium of Northern California BIRCWH programs;
and 7) the School of Medicine Mentoring Academy to optimize mentoring experiences. To support this scholar,
our BIRCWH program will continue to leverage campus expertise in the topical areas of her research.

Public health relevance
PROJECT NARRATIVE In this administrative supplement to our UC Davis BIRCWH program (PI, Dr. Nancy Lane), we propose to build on the experience and achievements of our previous 21 years of the program to advance, promote, and achieve interdisciplinary training and mentoring of team-based science for the next generation of researchers in women's health and sex differences. We are requesting to continue supporting our BIRCWCH Scholar who is from an underrepresented minority group and disadvantaged background to our program for two years. We believe that our BIRCWH faculty, mentors, and this additional Scholar will work to improve the health of women and to improve our knowledge and understanding of the mechanisms and manifestations of sex differences in health and disease as well as of the unique afflictions women face with the ultimate goal of more effective prevention, diagnosis, and treatment.